Design, Development, Implementation and Validation of a Mechanistic Physiologically-based Pharmacokinetic (PBPK) Framework for the Prediction of the In Vivo Behaviour of Supersaturating Drug Products

Project Summary / Abstract Physiologically-based pharmacokinetic (PBPK) models can separate drug/formulation characteristics from the underlying physiology and are well positioned to predict PK including inter-individual variability. A further advantage of Population PBPK is the ability to extrapolate from a model validated for a particular drug/formulation in one population (e.g., healthy volunteer) to another population (e.g., elderly or paediatric) provided the physiological differences are sufficiently well characterised. The Simcyp Population-Based Simulator includes a sophisticated oral absorption module which can simulate clinical trials predicting inter-individual variability rather than just an “average person”. This project aims to incorporate state-of-the art mechanistic models for handling supersaturation and precipitation (S&P) properties of poorly soluble drug products. S&P properties can have a major influence on the overall bioavailability of such compounds. Thus, the ability to anticipate these properties from in vitro experiments and extrapolate to in vivo outcomes can be critical to a drug development program; where appropriate formulation strategies can be followed to either prevent precipitation or mitigate its impact. The PBPK models require: drug and formulation-specific information; mechanistic algorithms for not only precipitation itself (such as, but not only, classical nucleation theory) but also the numerous other processes occurring within the gastrointestinal tract and the associated physiological and anatomical parameters and their inter-individual variability, which play an important role in supersaturation/precipitation behaviour in vivo. This includes gastric and small intestinal luminal fluid volumes; gastrointestinal transit times of fluids, fine particles and intact single unit dosage forms; regional luminal pH; fluid viscosity, effect of excipients, etc. The new mechanistic models are to be incorporated into both the Simcyp platform itself and crucially into separate complementary tools for modelling appropriate in vitro experiments such as media transfer experiments. This parallel implementation is essential for understanding, testing and parameterising the models. The existing standalone Simcyp In Vitro Analysis (SIVA) toolkit provides an ideal framework within which to add new modelling algorithms. At least eleven model drug products dosed under various conditions and exemplifying different mechanisms of supersaturation and precipitation are considered to be used for performance verification of the developed models and physiologies the results of which will be disseminated to the general scientific community through appropriate channels.

Public health relevance
Project Narrative The project aims to develop physiologically-based mechanistic supersaturation and precipitation models along with the support database of physiology and its variability. The overall goal of the project is to provide a physiologically-based pharmacokinetics (PBPK) modelling and simulation platform for the assessment of new product performance and comparison of test products to the reference products considering inter- and intra- individual variability. The performance of the developed model and database will be validated against clinical pharmacokinetic data of the available drug products. The developed models/algorithms will be implemented within the Simcyp Simulator and the separate, but complementary, Simcyp In Vitro data Analysis (SIVA) Toolkit for model assessment and parameter estimation as required.